Core A: Admin Core

Core A Summary
The Administrative Core (Core A) will continue to provide all administrative and fiscal support for the Program.
Administrative support will include arranging meetings, conference calls, Zoom conferences, handling all PPG-
related correspondence, preparing documents, ensuring that all vertebrate animal and human subjects
documentation is current, and submitting collaborative manuscripts. Fiscal support will include maintaining and
reconciling accounts, preparing budgets, and arranging subcontracts. The Administrative Core will also assist
with noncompeting and competing renewals, organize monthly PPG meetings, and annual retreats. Core A
will importantly, continue to maintain a secure file server for data sharing for the project leaders to easily
access and share data among the 3 institutional sites. Core A also continues to partner with Information
Technology at LJI to maintain access to high performance computers for the computational and bioinformatic
needs for high dimensional data analyses. The Administrative Core will also work with Core C for clinical
biospecimen shipment among the sites.